Examining trauma and demoralization as factors influencing treatment engagement for Black women with SUD returning from prison

Program Summary/Abstract
People who experience incarceration and have mental health challenges are disproportionately Black and
Latinx, and low-income. This group experiences financial hardships regardless of incarceration due to racism
and other forms of discriminations, with associated negative health outcomes. These financial issues have a
direct impact on health, create barriers to employment and housing, stress social networks, contribute to
feelings of exclusion and contribute to recidivism, all of which are health determinants. The goal of the parent
award is to intervene at the community level to reduce financial difficulties of individuals with incarceration
histories and mental health challenges, who are predominantly Black and Latinx.
The proposed diversity supplement will explore experiences of trauma, stigma, and demoralization among
Black women with histories of a substance use disorder (SUD) and/ or SUD treatment, recently released from
incarceration. Incarcerated populations are often presenting with mental health conditions, including substance
use disorders (SUD), with an estimated 60% of those incarcerated meeting criteria for a SUD. In the last two
decades there has been an 525% increase in the incarceration rate for women, and in 2021 Black women
were incarcerated at 1.6 times the rate of White women. Furthermore, consistent findings highlight high rates
of victimization among incarcerated women, and it is hypothesized that trauma exposure is a gender-specific
pathway into the carceral system. Research has identified that for several women this pathway is in part due
the presence of mental health conditions, including SUDs. Stigma associated with both addiction and legal
involvement is one of the many barriers individuals face as they reenter the community and initiate community-
based SUD treatment. Embodying multiple stigmatized identities, formerly incarcerated Black women with
SUDs navigate a reentry experience that is unique and nuanced. Implementing Community-Based
Participatory Research (CBPR) methods this proposal will explore how these intersecting identities (race,
gender, person who uses substances, incarceration history) and compounded experiences (pre-incarceration
trauma, carceral trauma, internalized stigma, demoralization) impact treatment seeking behaviors and
decisions. Our CBPR process incorporates learning from and partnering with community stakeholders to
identify opportunities that can improve treatment strategies and reentry experiences for the target population,
and inform the development of a harm reduction, community-based, and culturally relevant intervention.

Public health relevance
Project Narrative- Parent Award This innovative proposal will address financial wellbeing, an often overlooked but important factor impacting reentry for justice-involved people with mental health challenges, who are disproportionately Black and Latinx. This project will change community level determinants by integrating financial capability supports (one-on-one coaching and access to financial tools and services) into existing services, and training bank and credit union staff to reduce discrimination. It will also support collaborative community efforts working towards upstream policy and legal reforms to reduce the incidence of those financial challenges.